Optimizing Research Methodology in a Multinutrient Study of Racially and Ethnically Diverse Children with ADHD and Emotional Dysregulation

PROJECT SUMMARY
This K23 award will solidify the applicant’s capacity to conduct independent patient-focused,
multicomponent dietary supplement clinical trials for mental health conditions. This proposal focuses on
attention-deficit/hyperactivity disorder (ADHD) in children. ADHD is a central element in an early causal pathway
to future depression, anxiety disorders, substance misuse, job and relationship failures, chronic health problems,
suicide, and premature death. It is, therefore, a major public health priority. Perhaps the most impairing single
feature of ADHD, which cuts across disorders and remains difficult to treat, is extreme emotional dysregulation
(anger, moodiness, and irritability). The candidate has conducted clinical trials in children and adults with ADHD
and emotional dysregulation that have shown benefit for a multinutrient dietary supplement containing all known
vitamins and essential minerals. Limiting the reach and generalizability of this promising intervention, previous
studies have included a majority of white, non-Hispanic participants; imprecise behavior change data; and limited
examination of the multinutrients’ mechanisms of action. This proposal addresses these key issues. Aim 1
proposes a community-based, qualitative study using focus groups with Black and Hispanic parents to elicit their
priorities concerning their child’s mental health and barriers to participation in research. Aims 2 and 3 propose
a feasibility and acceptability study (pilot clinical trial) of the intervention in Black and Hispanic children. The
study design will be informed by focus group feedback. Aim 2 tests real-time parent-reported behavior change
in their child based on a targeted problem identified by the parent. Aim 3 tests the at-home biospecimen collection
of blood and urine to initiate an examination of immune and neurotransmitter biomarker signals. Career
development areas align closely with the research aims, and include training in community engagement and
mixed methods to identify mental health priorities of diverse communities; mediator/moderator models and
neuroimmune factors that affect mental health in order to initiate biomarker investigation; and professional
development including leadership and grant writing skills. Career development will occur at a resource-rich
academic medical center. The application is bolstered by an interdisciplinary mentor team of intellectually,
racially, and ethnically diverse individuals. While this proposal focuses on ADHD and emotional dysregulation in
children, the applicant’s training and proposal results are expected to generalize to CIH research broadly, as the
NCCIH prioritizes increasing research participant diversity and examining biomarkers for mechanistic signals.
This K23 will provide the applicant with the training and preliminary data to be competitive for an R01 study of
the promising multinutrient intervention using refined data and biospecimen collection methods in a larger,
diverse sample while testing biomarker hypotheses, building on the award findings. This application will enable
the applicant to advance a larger program of research investigating multicomponent CIH interventions for patient
populations with emotional dysregulation across mental health diagnoses.

Public health relevance
PROJECT NARRATIVE Attention-deficit/hyperactivity disorder (ADHD) is a central component in an early causal pathway to future mental and physical health problems, relationship issues, suicide, and premature death, thus an important public health concern. A multinutrient dietary supplement has demonstrated promising benefit for ADHD and its often-accompanying feature, emotional dysregulation, in three randomized clinical trials, but in majority white, non-Hispanic populations. To increase diverse research participation, focus groups will seek input from racially and ethnically diverse communities on their needs and priorities to inform a feasibility study testing the acceptability of: 1) the multinutrient supplement; and 2) refined collection methods designed to reduce research participant burden and increase data sensitivity while exploring how the multinutrients confer benefit.